Animal Shared Resource

ANIMAL SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Animal Shared Resource offers integral support to CSHL Cancer Center members by providing high quality
animal housing, husbandry services, and technical and managerial support. In addition, highly trained
technicians offer advanced services as well as training on a variety of methods and skills, including: surgical
manipulations, post-surgery monitoring, blood and tissue procurement, tissue perfusion, and therapeutic and
virus administration. The Animal Shared Resource is led by Faculty Head Alea Mills, Ph.D. and Director Rachel
Rubino, D.V.M. The support provided by the Animal Shared Resource is critical for many research advances in
the CSHL Cancer Center. It has enabled researchers to develop innovative animal models for cancer, which
continue to be instrumental in uncovering the genetic and molecular basis of the disease. These include viral
transduction models, multi-allele reversible cancer models, and organoid orthotopic engraftment models of
human and mouse cancer. As the CSHL Cancer Center shifts to expand its preclinical and translational
research, animal models will become even more imperative. The Animal Shared Resource provides researchers
with the ability to move beyond cell culture and to explore cancer biology and cancer medicine in an appropriate
in vivo context. In summary, the Animal Shared Resource provides the Cancer Center with a complete set of
essential services and sophisticated technical support to facilitate cancer research and discovery. In the current
period, the Animal Shared Resource was used by 23 Cancer Center member laboratories (61% of members),
including investigators from all three Programs. This Shared Resource contributed to 58 publications by Cancer
Center members over this time period.

Public health relevance
ANIMAL SHARED RESOURCE- PROJECT NARRATIVE Not required per PAR-20-043